Contributors to FXTAS Progression

SUMMARY
Carriers of the FMR1 premutation have expanded CGG repeats at the 5’ UTR of this gene.
Carriers have a higher risk of developing fragile X-associated tremor/ataxia syndrome (FXTAS),
a progressive neurodegenerative disease accompanied by tremor and ataxia as well as deficits
in cognition, learning, and other neuropsychological issues (depression, anxiety).
Neurodegeneration in FXTAS is accompanied by increased oxidative stress, lower
mitochondrial bioenergetic capacity, limited unfolded protein response and a poorly
characterized neuroinflammatory process. Surprisingly, not all carriers of the premutation
develop FXTAS and the progression from milder to more detrimental stages is highly variable
even in subjects with comparable age. As of today, there is no cure for FXTAS or to prevent its
development. Exosomes are proposed to mediate pathophysiological signaling in a variety of
target cells and their concentration spike in diseases associated with inflammation. Here, we
hypothesize that circulating exosomes with detrimental cargoes are contributors to the onset
and/or the progression of the disease. To this end, we will characterize exosomes from plasma
obtained from sex- and age-matched noncarriers, carriers with and without FXTAS. The
thorough characterization will entail evaluation of number and size, miRNA, and protein
profiling. The characterization will serve as a platform to identify qualitative and quantitative
differences as well as to identify the involvement of different biological pathways. The putative
“toxic” effect of exosomes derived from carriers with and without FXTAS will be assessed by
evaluating the bioenergetics of target cells (neurons and glia). These studies will provide an
insight on the mechanism underlying the impact of exosomal components to the onset of
mitochondrial dysfunction (as it is observed in carriers with FXTAS) and the progression of
ataxia and tremors, key features of FXTAS-affected subjects.

Public health relevance
NARRATIVE We will characterize the composition of plasma exosomes from subjects affected with the late onset neurodegenerative disease fragile X-associated tremor/ataxia syndrome (FXTAS) compared to those age- and sex-matched carriers of the FMR1 premutation without FXTAS and non-carriers. In parallel, we will evaluate the effect of FXTAS-derived exosomes on cellular energy metabolism of neurons and microglia.